Childhood Allergy and the NeOnatal Environment in St Louis (CANOE-STL) and the Impact of Wheezing Illnesses on Neurocognitive Development of Preschool Children

Project Summary
Wheezing during preschool years is a common occurrence [1] causing significant healthcare burden [2] with
frequent unscheduled physician visits, ED visits, hospitalizations, and treatment with inhaled and systemic
corticosteroids along with other medications. Recurrent wheezing is often the antecedent to asthma, one of the
most common chronic diseases of childhood. Though there is evidence of significant neurocognitive problems
in children with other chronic health conditions such as oncological diseases, diabetes, heart disease, sickle cell,
and traumatic brain injury [3], the impact of recurrent wheezing illnesses and associated treatment on the
neurocognitive and emotional development of infants and preschool children has not been fully
characterized. The ECHO cohort study has been collecting neurodevelopmental measures in children after the
late preschool years; however, critical neurodevelopmental trajectories occur in early infancy [4]. Data suggest
that these trajectories can be affected by pre-natal conditions, socioeconomic status, stress, disease severity,
and/or medication use. A recent study, in non-asthmatic patients, showed that the use of systemic
corticosteroids, a frequently administered treatment for wheezing illnesses, was associated with changes in brain
structure [5]. Building on these findings, our overarching study objective is to understand the association
of recurrent wheezing illnesses and its associated treatment on the neurocognitive and emotional
development of infants and preschool children.

Public health relevance
Project Narrative With this study, we aim to understand the impact of recurrent wheezing illnesses on the neurocognitive development of preschool children with an exploratory aim to understand the impact of pre-natal maternal neuro-psychosocial and inflammatory states on neurocognitive development of preschool children. We also intend to recruit new participants, focus on activities that ensure retention and promote best practices for diversity, equity and inclusion of the research team and all aspects of the study.